Investigating Mechanisms of D. melanogaster Histone Locus Body (HLB) Initiation and Maintenance

PROJECT SUMMARY
Coordinated zygotic gene expression is necessary for the rapid cell divisions that lead to proper development.
This is especially true for the uniquely regulated replication-dependent histone genes. Histone proteins are
essential for compaction and regulation of the eukaryotic genome, and dysregulation of histone gene expression
leads to aberrant cell cycle timing, development, and lethality. In animals, genes encoding the histone proteins
are commonly clustered at one or several loci. The histone locus body (HLB) is a conserved collection of factors
that localize to histone loci and regulate histone gene expression. The HLB must initiate for the first time at the
histone genes during early embryogenesis. Then, histone expression must be maintained by the HLB through
development and subsequent cell divisions. While we have begun to define HLB initiation mechanisms, we
cannot yet describe how the HLB is maintained. Describing HLB initiation and maintenance mechanisms is
especially important to the fields of stem cell differentiation and regenerative medicine that require mature cells
to adopt embryonic gene regulatory patterns.
The histone genes are amongst the most conserved genes in eukaryotes. While many components of
the HLB are also conserved between animals, manipulating the repetitive histone genes is prohibitively difficult
in most species and can lead to misexpression and developmental lethality. We therefore employ the powerful
model system Drosophila melanogaster in which we leverage histone transgenes that recruit HLB factors and
express histone genes, allowing us to manipulate cis elements and determine the effects on HLB formation and
gene expression. I hypothesize that mechanisms of HLB initiation early in development are the same as those
later responsible for HLB maintenance. I will test my hypothesis through two Specific Aims.
In Aim 1, I will compare mechanisms of HLB initiation and maintenance by removing important cis
elements after initiation and testing for HLB maintenance. I will also perform ChIP-seq in synchronized cells to
determine if important HLB factors are associated with the locus throughout the cell cycle. In Aim 2, I will define
the latent potential of differentiated tissues to activate HLB initiation mechanisms. First, I will induce mitotic
recombination in larval tissues to determine if the HLB can initiate at a new locus in non-embryonic tissues. I will
also mentor an undergraduate student who will use a parallel transgenic system, as I designed a transgene that
I predict will delay initiation until later in embryogenesis.
Overall, these aims allow us to illustrate how and when histone proteins are regulated and in what
contexts factors target these crucial genes for regulation. I designed these experiments, in collaboration with my
sponsor and co-sponsor, to address critical knowledge gaps in our field, develop expertise in a broad array of
techniques, and provide me with the training opportunities required to become an independent researcher.

Public health relevance
PROJECT NARRATIVE Histone genes, which encode DNA organization and packaging proteins, are meticulously controlled during early development: incorrect histone regulation leads to genome instability, delays in cell division, and developmental defects. We aim to define the initiation and maintenance mechanisms of histone regulation, both of which are critical to successful development.